ADMINISTRATIVE CORE

Core A is designed to provide the administrative structure necessary to oversee all components of this program. This program requires the seamless cooperation and integration of investigators at three institutions, Brigham and Women's Hospital, Roswell Park Cancer Institute, and the University of New Hampshire. The core will assure the coordination of these components and will provide for oversight and leadership of the scientific, administrative and fiscal aspects of the program.

Public health relevance
RELEVANCE (See instructions): Core A is designed to provide the administrative structure necessary to oversee all components of this program. The core will assure the coordination of these components and will provide for oversight and leadership of the scientific, administrative and fiscal aspects of the program.